TMC gene function in sensory hair cells

PROJECT SUMMARY
Mutations in transmembrane channel-like gene 1 (TMC1) underlie dominant, progressive hearing loss (DFNA36)
and recessive nonsyndromic hearing loss (DFNB7/B11) in humans (Kurima et al., 2002). Similarly, semidominant
and recessive alleles of Tmc1 cause hearing loss in Beethoven (Bth) and deafness (dn) mutant mice (Vreugde et
al.,2002; Kurima et al., 2002). Tmc1 is a member of the Tmc gene family that includes seven other paralogs in
mammals (Keresztes et al., 2003). Tmc1 and closely related Tmc2 are expressed in auditory and vestibular hair
cells of the mouse inner ear and are necessary for mechanosensory transduction. In prior work, funded by this
RO1, we demonstrated that TMC1 is a pore-forming subunit of the hair cell transduction channel and contains four
transmembrane domains (S4-S7) that line the ion channel pore (Pan et al., 2018).
With compelling evidence in hand demonstrating that TMC1 is a major component of the channel, we can now
use this information to tackle both basic science and translational research questions that were previously
intractable. This project is organized around five independent, but related specific aims focused on understanding
the structure and function of TMC1 in isolated systems and in native hair cells. In addition, we will explore novel
techniques for restoration of auditory function in mouse models of the human genetic inner ear disorders DFNA36
and DFNB7/11.
We have optimized protocols for expression and purification of high-quality mammalian TMC1 protein. For aims
1 and 2, we will use purified protein to generate the cryo-EM structures of mammalian TMC1 and will examine the
function of isolated TMC1 channels in heterologous systems. For aim 3, we will characterize the N- and C- termini
of TMC1 and TMC2 and identify motifs of these regions that confer unique properties to these proteins. We will
express TMC1 and TMC2 proteins bearing N-terminal mutations in hair cells of Tmc1/Tmc2 double mutant mice
and assay for changes in the properties of hair cell sensory transduction. Likewise, for aim 4, we will examine the
interaction between TMC1 and its binding partner TMIE using Tmie-null mice. We will express WT or mutant TMIE
constructs in hair cells of Tmie-null mice and assay for functional differences in hair cell transduction. For aim 5
we will explore a novel therapeutic approach for targeting all dominant and recessive Tmc1 mutations in auditory
and vestibular hair cells using a single therapeutic strategy.
Based on new information about the structure and function of TMC1, projects included in this proposal will allow
us to expand our understanding of sensory transduction in auditory hair cells and develop a cutting-edge
translational approach suitable for treating both dominant and recessive TMC1 mutations that cause genetic
hearing loss in humans.

Public health relevance
NARRATIVE We discovered that Transmembrane channel-like 1 (TMC1) functions as a key protein that converts sound information into electrical signals in sensory hair cells of the inner ear. Over one hundred different mutations have been identified in TMC1 that cause hereditary hearing loss in humans. Here we propose experiments to help better understand the structure and function of TMC1 and develop strategies to translate our discoveries into therapeutics for the treatment of hearing loss in patients who carry TMC1 mutations.